PAI-1-mediated early-onset endometrial cancer

ABSTRACT
PAI-1-mediated early-onset endometrial cancer
Over the last 15 years, an increase in obesity-associated endometrial cancer has been observed, coinciding
with the globesity epidemic in the US. These patients are 15-30 years younger than the typical patient
demographics, and thus experience clinical burden linked to fertility preservation and disease recurrence. To
understand the contribution of obesity to early-onset endometrial cancer, we recently found increased
infiltration of adipose stromal cells (ASCs) in endometrial microenvironments of obese patients. Preliminary
studies implicate that ASCs directly influence expression changes of loci associated with intercellular
permeability and polarity (IPP) in endometrial epithelial cells (EECs). Single-cell transcriptomic profiling has
further identified that plasminogen activator inhibitor-1 (PAI-1), an abundant ASC-secreted adipokine, plays a
key role in deregulating IPP functions. Therefore, we hypothesize that aberrant PAI-1 signaling interferes with
IPP transcription, disrupting intercellular communication homeostasis to promote neoplastic EECs. In Aim 1,
the contribution of ASC-secreted PAI-1 to transcription reprogramming of IPP will be determined in EEC
exposure models. When PAI-1 is tethered to LDL receptor-related protein 1 (LRP1) on the cell surface, the
internalized signaling engenders E3 ubiquitin-mediated degradation of SMAD4 that attenuates TGFβ tumor-
suppressive transcription program. Single-cell proteomic profiling will confirm whether IPP repression
preferentially occurs in SMAD4-underexpressed cell subpopulations of primary tumors in young obese
patients. In Aim 2, phenotypic influences of PAI-1 on cellular transformation will be assessed in EEC exposure
models with IPP knockdowns or knockins. Dye-transfer assay and atomic force microscopy will be used to
probe intercellular properties of permeability and polarity in EECs and to determine whether these altered
biophysical features represent a neoplastic phenotype of EECs. When validated in a tissue microarray panel of
230 tumors and 30 uninvolved normal samples (sample size justified), decreased expression of candidate loci
is expected to correlate with the young age of patients with high body mass indices (BMIs). In Aim 3, PAI-1-
mediated recruitment of DNA methyltransferases will be examined in susceptible IPP loci. Persistent exposure
of EECs to PAI-1 will facilitate methylation propagation within IPP promoters, leaving permanent epigenetic
footprints in the neoplastic progeny. When confirmed in an endometrial cancer cohort, increased DNA
methylation of these candidate loci is frequently present in primary tumors of young obese patients. The
proposed study not only gives insights into a novel role of PAI-1 in early-onset endometrial cancer, but also
identifies epigenetic biomarkers for cell-free DNA monitoring of young patients at risk of developing future
recurrence.

Public health relevance
PROJECT NARRATIVE The incidence of early-onset endometrial cancer has risen in young obese patients. The proposed study will result in the development of screening methods using methylation markers in cell-free DNA testing. Furthermore, given PAI-1 plays a role in comorbidity complications, the study may open new preventive measures targeting downstream PAI-1 pathways.